Task E12: Nonclinical Services for Development of Interventional Agents for Resistant Pathogens

This contract provides for a variety of preclinical therapeutic assessment services under the NIAID Preclinical Services for the Development of Interventional Agents Program